2024 Lymphatics Gordon Research Conference and Seminar

PROJECT SUMMARY
The objectives of the 2024 Gordon Research Conference (GRC) “Lymphatics” are to present state-of-the-art
research on the lymphatic vascular system, to fuel scientific exchange across race and expertise, and to
spearhead new ideas and collaborations. The meeting will bring together investigators in all racial backgrounds
and from all career stages converging on lymphatics as one common theme. Specific Aims are (1) To present
conceptual advances in research of the lymphatic vascular system and its pathologies; (2) To discuss paradigm
shifting findings of lymphatics in different organ systems and their contribution to disease; (3) To integrate
knowledge from different disciplines; and (4) To nurture underrepresented, low-income, disabled, women
scientists and junior investigators. Sessions will cover conceptual advances in development and disease of
lymphatic vessels from basic aspects to potential clinical application. The meeting will in particular, highlight
recent insights into the diversity and organ-specificity of lymphatic endothelium. Novel molecular regulators for
lymphatic vasculature during bone development, Schlemm’s canal in the eye and lacteals in the intestine will be
discussed. New factors for regulating lymphangiogenesis and lymphatic integrity will be introduced. Advances
in research of lymphatic malformations, lymphedema and other congenital lymphatic diseases will be discussed.
Meeting will also present emerging concepts on the role of lymphatics in atherosclerosis, myocardial infarction,
and congestive heart failure. Paradigm shifts in the field will be presented, crosstalk between lymphatics and
immune system discussed. Advances in understanding how lymphatics contribute to disease, including
cardiovascular inflammation, cancer, autoimmune and neurodegenerative diseases will be highlighted. A main
goal for this meeting is to serve as a platform to promote diversity, inclusivity and equality. Abundant opportunities
for the presentation of research by underrepresented minorities and early career investigators will be provided.
Gordon Research Seminar on Lymphatics organized by junior investigators solely provides additional
opportunities for junior investigators to present their work and form collaborations. Aside from presentation and
poster sessions, a career development session will be held during Gordon Research Seminar. A “Power Hour”
to discuss racial and gender biases and burdens placed on URM in science along with a patient session to allow
researchers to learn from patients and a special session hosting NIH official to educate us about NIH’s initiatives
and efforts to support lymphatic research will be held. The sponsoring organization GRC is dedicated to
advancing the frontiers of scientific research. In accordance with its mission, this conference will place an
emphasis on the presentation of unpublished data, high quality science and rich discussions in many fields such
as cardiovascular disease, cancer, immunology, metabolism and neurobiology. We anticipate that URM and
junior investigators will rise up as future leaders so future of lymphatic research will be flourished with diversity.

Public health relevance
PROJECT NARRATIVE Lymphatic vessels are important for the normal function of every organ system and for many physiological processes. This conference will present novel insights into the role of lymphatics in diseases of different organ systems including heart disease, plaque deposition in the arteries, lung inflammation, autoimmune diseases, Crohn’s disease, Alzheimer disease and cancer. Progress in understanding and treatment of lymphatic malformations and lymphedema will also be discussed.